An innovative, interactive mHealth smartphone app to improve reproductive health outcomes for minority male teens, providing medically-accurate information for prevention of pregnancy, HIV, and STIs.

Abstract MetaMedia, and partner Healthy Teen Network, will develop a mobile application aimed at reducing teen pregnancy and sexually transmitted infections (STIs) among Latino and African American men aged 15-19. In the U.S., teen pregnancy, teen births and STIs affect African American and Latino youth in greater proportion compared to other youth. A comprehensive literature search revealed that multiple sexual and reproductive health apps exist for adolescents in general; however, none were found that specifically address the needs of diverse young males. And none were evaluated for behavior change. During the SBIR Phase 1 study, the project team will achieve three aims/objectives. First, it will conduct a five-phased qualitative formative study to guide the development of MAPP. The formative study will obtain: 1) youth suggestions/ideas for app content, features, branding, and visual design; 2) youth feedback on the readability, word/language usage, and amount and phrasing of the app's text; 3) youth feedback on the mechanics, educational messages, and interest of an interactive game(s); 4) youth feedback on usability and navigation by conducting a user-centered walkthrough of the app; and 5) quality assurance feedback from project team staff. Second, it will develop a mobile app that strategically addresses a prioritized set of determinants of five sexual health behaviors directly related to preventing pregnancy/STIs while applying principles and preferences of how young men learn. These behaviors include: 1) delay the onset of sexual initiation/reduce the frequency of sex, 2) increase correct and consistent use of condoms, 3) increase support to female partners in the correct and consistent use of effective forms of contraception, 4) reduce the number of sexual partners/concurrent sexual partners, and 5) increase visits to health centers for STI testing and treatment. And third, it will develop an educational and entertaining game that reinforces key behavioral messages presented in MAPP. In the SBIR Phase II of the study, MAPP will be rigorously evaluated using adequately powered samples. In addition, a commercialization and marketing plan will be developed to maximize MAPP's commercialization potential and wide dissemination to youth and youth-serving professionals. MetaMedia, a small business with 35 years of experience, is a pioneer in adapting emerging technologies to improve learning and performance. Healthy Teen Network, a national nonprofit organization with 30 years of experience, has a proven track record in applying evidence approaches to develop and evaluate teen pregnancy and STI prevention interventions. Their organizational missions and experience create an ideal partnership for this project.

Public health relevance
Project Narrative The findings of the MAPP study in SBIR Phase I will increase the sexual and reproductive health (SRH) field's understanding about: 1) how to develop an SRH mobile app for young men, including technical innovations such as educational and engaging games; 2) the effectiveness and satisfaction of the app's methodologies, components and aesthetic characteristics specifically designed for African American and Latino young men and their learning styles; and 3) the prioritization of psychosocial determinants that are essential in supporting young men's healthy sexual behavior. During SBIR Phase II, the commercial app will be completed with all content and functionality, and the study will rigorously evaluate MAPP and examine if it is effective at changing five sexual behaviors – an area of research that is currently not available to the SRH field. Findings from the MAPP study will also inform other public health fields interested in developing mobile apps that aim to change health behavior, especially among Latino and African American young men.